Pediatric dysphonia: Multidisciplinary advances to improve voice quality outcomes

ABSTRACT
Childhood voice disorders can have profound influences on communication that in turn impact physical,
cognitive, and emotional development. Surprising to many, the prevalence of pediatric voice disorders is high,
yet systematic bench-to-bedside research targeting pediatric voice assessment is severely lacking. This
innovative proposal seeks to advance our knowledge of the basic properties of pediatric dysphonia and to
develop and improve laboratory methods and clinical protocols for quantifying pediatric voice quality (VQ). The
proposal addresses three fundamental issues as yet unanswered. First and foremost, we challenge the tacit
assumption that the primary dimensions of pediatric VQ, to be assessed, analyzed, and tracked, are the same
across age and vibratory source. These assumptions have yet to be tested, though they permeate clinical
practice and research, despite the fact that there are marked differences in the vocal anatomy and physiology
between children and adults and between vibratory sources that can impact VQ. To this end, Aim 1 involves a
systematic multidimensional scaling approach to establish the dominant voice qualities associated with glottal
and supraglottal vibratory sources in pediatric dysphonia. Aim 2 explores the potential role of pitch perception
to inform us about pediatric dysphonia and to better accommodate different vibratory sources. While standard
VQ assessments do not distinguish among possible vibratory sources, experts anecdotally note very different
source-dependent VQ. In doing so, we address the vexing problem posed by aperiodic signals (e.g., Type III)
in pediatric voices with supraglottal sources by invoking recently developed, pitch-based measurement
methods. In Aim 3, we use a theoretical framework of perception to quantify VQ along primary dimensions to
support: 1) discovery of objective indices of VQ, 2) development of robust perceptual measures of VQ, and 3)
development of novel ratio-level scales ideal for clinical use as diagnostic and outcome measures. Such scales
enhance clinical perceptual evaluation of voice to support quantitative comparisons among pre-treatment, peri-
treatment, and post-treatment outcomes to provide robust, evidenced-based outcome measures. The success
of this proposal is bolstered by the uniquely qualified expert team that has been assembled. The team includes
collaborators that are expert pediatric voice clinicians, led by Dr. Alessandro de Alarcon who is a foremost
pediatric laryngologist, and a group with years of experience using innovative methods to investigate voice
quality in adults, including Drs. David Eddins, Rahul Shrivastav, Supraja Anand, and Erol Ozmeral, with
expertise in voice, speech, hearing, and signal processing. Together, this multi-disciplinary team has the
knowledge, experience, expertise, and multi-site resources to efficiently and effectively address the limitations
noted above. This pre-translational and translational research has the promise to substantially advance the
field of pediatric voice and vocal heath care with the potential to lead to formal clinical trials.

Public health relevance
NARRATIVE Childhood voice disorders can have profound influences on communication that, in turn, can impact physical, cognitive, and emotional development. Here we leverage the expertise of a multidisciplinary team to develop objective measures of voice quality, specifically targeting the pediatric population in the first NIH-funded laboratory study of pediatric voice quality perception. This pre-translational research introduces a theoretical framework grounded in principles and models from auditory perception and is focused on improving diagnostic procedures and treatment outcome measures for children.